Center for Aging in Diverse Communities: Ending Health Inequities in Older Adults

PROJECT SUMMARY/ABSTRACT – OVERALL
The US population is rapidly aging and becoming more diverse. Yet substantial disparities in health outcomes
remain for older adult populations from diverse communities. In order to achieve health equity for older adults,
NIA’s Strategic Directions for Research, 2020-2025 Goal F is to ‘understand health disparities related to aging
and develop strategies to improve the health status of older adults in diverse populations.’ Accordingly, the
Center for Aging in Diverse Communities (CADC) at the University of California San Francisco’s research
theme is to understand multilevel social and behavioral mechanisms of health disparities impacting older adults
and develop interventions to achieve health equity. Growth and diversification of the research workforce to
investigate the mechanisms of health disparities and identify solutions for older adults is crucial. NIA’s Goal G
is to ‘support the infrastructure and resources needed to promote high-quality research’, a goal shared by
CADC. A Resource Center for Minority Aging Research (RCMAR) since 1997, CADC has a successful track
record of providing pilot study funding, comprehensive training in behavioral and social research on aging and
older adults (aging-related health disparities research), and longitudinal mentorship of early-stage diverse
researchers until they obtain independence. CADC’s Faculty have a multiplicity of social and behavioral
focused aging-related health disparities research expertise and a wealth of experience mentoring diverse
early-stage investigators in establishing sustained research careers. CADC has closely mentored 99 diverse
Scientists (20 in the 2018-2023 cycle) from traditionally excluded and underrepresented in research groups.
CADC’s goal for this proposed renewal is to build on our position of strength to advance NIA's Strategic Plan.
With a focus on our research theme, CADC will accomplish the following Specific Aims: 1) select 3-4 CADC
Scientists per year, provide pilot study funding, train them in social and behavioral research methods tailored to
their pilot and subsequent research and mentor them to develop independent, sustained careers in aging-
related health disparities research; 2) develop methodological resources as needed by our Scientists to
promote and build capacity in utilizing optimal methods in aging-related health disparities research and
disseminate these resources through publications and our website; 3) expand joint research and mentoring
collaborative activities between CADC and our newly affiliated Hispanic serving institution, University of
California Merced (UCM), and between CADC and other UCSF NIA/NIH sponsored centers, programs, and
aging-related researchers; 4) maintain CADC’s structure, processes, and culture of diversity, equity, inclusion,
and accessibility (DEIA) to effectively mentor CADC Scientists and coordinate all CADC Core activities and
external activities with other RCMARs and the RCMAR Coordinating Center. Through impactful research,
CADC Faculty and Scientists will contribute to improving the health status for older adults in diverse
populations and achieving health equity.

Public health relevance
NARRATIVE For 25 years, the RCMAR Center for Aging in Diverse Communities (CADC) at the University of California San Francisco has been successfully delivering a robust mentoring and training program and providing a culture of equity and inclusion for early career researchers from diverse backgrounds who will enhance the aging-research workforce. In this renewal, CADC’s multidisciplinary faculty have the experience and expertise to train and mentor this next generation of researchers focused on aging-related health disparities. Through impactful research, CADC Faculty and Scientists will contribute to improving the health status for older adults in diverse populations and achieving health equity.